Developing the Context-Aware Multimodal Ecological Research and Assessment (CAMERA) Platform for Continuous Measurement and Prediction of Anxiety and Memory State

Summary/Abstract (30 line max):
This project seeks to develop the CAMERA (Context-Aware Multimodal Ecological Research
and Assessment) platform, a state-of-the-art open multimodal hardware/software system for
measuring human brain–behavior relationships. CAMERA will record neural, physiological,
behavioral, and environmental signals, as well as measurements from ecological momentary
assessments (EMAs), to develop a continuous high-resolution prediction of a person’s level of
anxiety and cognitive performance. CAMERA will provide a significant advance over current
methods for human behavioral measurement because it leverages the complementary features
of multimodal data sources and combines them with interpretable machine learning to predict
human behavior. A further distinctive aspect of CAMERA is that it incorporates context-aware,
adaptive EMA, where the timing of assessments depend on the subject’s physiology and
behavior to improve response rates and model learning. Our initial work on CAMERA focuses
on predicting anxiety state and concurrent memory performance, but the platform is flexible for
use in various domains.
Our work on CAMERA consists of two phases. First, in the R61 phase, we will develop the
CAMERA hardware/software framework, which includes methods for recording continuous
neural, physiologic, audiovisual, and smartphone-usage data (Aim 1) and synchronizing these
signals with intermittent EMAs (Aim 2). After demonstrating that CAMERA can successfully
combine multimodal features to predict a subject’s anxiety state and memory efficiency (Aim 3),
we will proceed to the R33 phase of the project. In the R33, we will use CAMERA in conjunction
with closed-loop neurostimulation to modulate the subject’s anxiety state and associated
memory performance (Aim 1), and to characterize the causal effect of modulation on neural,
physiologic, and behavioral biomarkers (Aim 2). Beyond our initial work in the domain of anxiety
and memory, we anticipate that CAMERA will have widespread impact by providing a general
platform for exploratory and hypothesis-driven research on various aspects of complex human
internal states, behavior, and cognition in real-world environments while minimizing burden on
subjects.

Public health relevance
Project Narrative (3 sentences max) This project builds the CAMERA (Context-Aware Multimodal Ecological Research and Assessment) platform, which will fuse diverse data signals from a range of unobtrusive sensors to continuously predict transient internal states and level of cognitive function. This project will identify new features of human neural activity, physiology, behavior, and environment related to memory and anxiety (R61), and test whether we can use multimodal data to more accurately identify and modulate anxiety and memory performance states (R33). CAMERA will also open a pathway towards the use of multimodal data and machine learning for naturalistic research and translational studies related to other complex human internal states and behaviors.